Elucidating the synergistic role of tau and α-synuclein in neurodegeneration and cognitive decline through mitochondrial dysfunction

Project Summary
Alzheimer’s disease (AD), followed by Parkinson’s disease (PD), are the most common age-associated
neurodegenerative diseases, neither with cure or sufficient disease-modifying treatment. AD is primarily defined
by pathologies of amyloid- and tau proteins, while PD is defined by -synuclein (α-syn) protein deposits.
However, these pathologies often coexist in both AD and PD and may act synergistically to enhance
neurodegeneration. In line with this, co-morbid tau and α-syn pathologies have been found in post-mortem brain
tissue of AD and PD patients. One region affected in both diseases is the basal forebrain, a region associated
with cognition, in which the loss of learning and memory associated neurons in both AD and PD is thought to
underlie cognitive decline and dementia. Impaired mitochondrial function has also been associated with AD and
PD, with recent studies demonstrating tau and α-syn disrupting mitochondrial respiration in AD and PD cell
cultures and rodent models. However, it is currently not known how tau and α-syn aggregation synergistically
affect neuronal mitochondria and how this may contribute to cognitive dysfunction and neuron death. To model
this co-pathology, I am using C. elegans due to its rapid aging, conserved neurobiology, and ease of genetic
manipulation, allowing for highly mechanistic investigations linking molecular mechanisms with behavior.
Transgenic strains expressing human tau, human α-syn, or human tau and human α-syn together in all neurons
will be used to model proteotoxicity in AD and PD contexts. My preliminary data indicates that the combination
of tau and α-syn enhances cognitive decline compared to tau alone or α-syn alone. Neurodegeneration will be
investigated through imaging studies, evaluating neurons within the learning and memory circuitry when tau and
α-syn are present. Biochemical analyses will reveal the pathological species of tau and α-syn associated with
the co-pathology. The potential reversibility of neurodegeneration and cognitive decline will be tested through
the degradation of tau, α-syn, or their combination via the auxin-inducible degradation system in live C. elegans.
To study mitochondrial dysfunction, mitochondrial morphology and bioenergetics will be assessed when tau and
α-syn are expressed in all neurons. Morphological data will be obtained via super-resolution microscopy, while
respiration will be measured using Seahorse. Novel mitochondrial genes altered by the combination of tau and
α-syn will be identified by RNA-sequencing specifically in learning and memory neurons. The top genes will be
tested for their role in neurodegeneration and cognitive decline. Finally, we will verify the role of mitochondrial
respiration in the toxicity of tau and α-syn co-pathology using human neuronal iPS cells. The overall goal of this
work is to shed light on the mechanisms of mitochondrial dysfunction and neurodegeneration in AD and PD and
identify potential therapeutic targets to treat cognitive decline.

Public health relevance
Project Narrative Alzheimer’s disease (AD), followed by Parkinson’s disease (PD), are the most common age associated neurodegenerative disorders, both with no cure or disease-modifying treatments. Pathologically, both present with the toxic protein aggregates tau and α-synuclein which are associated with mitochondrial dysfunction, neurodegeneration, and ultimately cognitive decline. This study aims to uncover the mitochondrial mechanisms of neurodegeneration brought on by the co-pathology of these protein aggregates, with an overarching goal of identifying potential therapeutic targets to treat AD and PD dementias.